Developmental Regulation of Retinal Microglia

PROJECT SUMMARY
Microglia, the resident neuroimmune cells of the CNS, play central roles in retinal development, homeostasis
and disease. It is a priority to understand how retinal microglia and other ocular myeloid cell populations are
established during development and maintained in adult under diverse conditions. In this study we investigate
the recruitment and development of retinal microglia and relationship with resident ocular macrophages at
multiple stages of development. The first aim will use lineage tracing to track the seeding and differentiation of
microglia from subsets of myeloid progenitors in embryonic retina and the role of cell death in this process. The
second aim will define whether there is postnatal infiltration of myeloid cells into retina, the role of cell death
and relationship to retinal microglia. The third aim will test the role of TGFß signaling in regulating the
development of retinal microglia at embryonic and postnatal ages. This study will provide mechanistic insight
into how retinal microglia recruitment and development are regulated. Since there are parallels in microglia
function in both development and disease, this may ultimately inform our understanding of how resident
myeloid cell populations are regulated and participate in degenerative disease processes resulting in loss of
vision.

Public health relevance
PROJECT NARRATIVE: Microglia play central roles in retinal development, homeostasis and disease so it is important to understand how retinal microglia and related ocular myeloid cell populations are established during development and maintained in adult under diverse conditions. This study will investigate the ontogeny and recruitment of retinal microglia, the cues and pathways involved and their relationship with resident ocular macrophages at multiple stages of development. Ultimately this may shed light on regulation of these myeloid populations in development as well as in healthy or diseased adult retina.